Admin Core

PROJECT SUMMARY
The MPRC Administrative Core has as its goal the provision of services to allow the Center and its Cores to
operate as a smooth-running, productive, dynamic, and innovative unit that reaches across the university and
to the broader community of population research. The Admin Core provides leadership and strategy for the
Center through the Center Director, Associate Director, and Executive Committee faculty roles. This includes
advocating for MPRC within the university, and acting as liaison to university administration across its
departments, colleges, and schools. The Administrative Core Coordinator, as a full-time staff member, serves
a similar function at the level of the unit administrators across our Faculty Associates academic departments.
Everyday functions such as Associate and Affiliate membership application and record-keeping are performed
by the Admin Core. The Admin Core provides services to the MPRC Executive Committee including meeting
preparation and follow-up, and maintaining and retrieving as needed the “institutional memory” of the MPRC.
The Admin Core provides logistical and administrative support to researchers for vital functions including
external grant submission and management, and for research oversight, compliance, and for research
dissemination. The Admin Core provides the administrative services to maintain a moving target of 80 to 90
Faculty Associates, plus those Associates’ sponsored Internal and External MPRC Affiliates. These include
resident and visiting scholar UMD paid or unpaid employee appointments. The Admin Core’s information
services to the Associates include assistance with writing research press releases, preparation of weekly or bi-
weekly electronic circulars of population research news to Associates and Affiliates, and semi-annual
Newsletters advertising recent and upcoming MPRC activities to a wider audience. The Admin Core provides
support to the Scientific and Technical Core and the Development Cores. It provides highly efficient
administrative staffing services to those Cores, including handling of seed grant applications, reserving
collaborative and workshop space, tracking of Associates’ and Affiliates’ participation in MPRC activities, and
enabling access to both MPRC physical facilities and to university privileges ranging from electronic and library
borrowing card provision to payroll system engagement. The physical facilities overseen by the Admin Core
include state-of-the-art meeting and conference rooms, collaborative spaces, restricted data laboratories, and
offices of MPRC staff and faculty directors, resident and visiting population scientists, and research assistants.
The Admin Core also provides support services that are vital for the logistics of conferences and symposia
organized by MPRC and held in both MPRC and other campus facilities.